Impact of social determinants of health on post-hospitalization outcomes and goal-concordant care in patients with advanced heart failure

1 Background: Social determinants of health (SDoH) and healthcare inequities influence the advanced illness
2 experience of patients with heart failure (HF). HF is a serious, chronic, and progressive clinical syndrome
3 affecting over 6 million (and rising) adults in the U.S. HF hospitalizations are reported in patients with late-stage,
4 advanced disease and these patients often experience repeat hospitalizations, nearly one-third die within one
5 year following a hospital admission for HF, and almost none survive past two years. Outcomes differ in racial
6 groups, with rates of hospitalizations for HF almost 2.5 times higher in Black patients than white. These health
7 disparities are further exacerbated as HF progresses to an advanced stage, where the general patient preference
8 is to remain at home after being discharged from the hospital after an acute HF incident. While generally
9 accepted that SDoH can be broadly used to identify patients at high risk for worse HF outcomes, what is not yet
10 known is whether any individual SDoH or groups of SDoH are key contributors, or drivers, of adverse health
11 outcomes or readmission after hospital discharge for an acute HF incident, particularly in diverse racial groups
12 with advanced HF. Therefore, we hypothesize that, by applying a combination of SDoH- and health-equity-
13 focused lenses of analysis to a highly diverse cohort of patients with advanced HF, we will be able to reveal the
14 individual, systematic, organizational, structural and/or community factors that drive post-hospitalization
15 outcomes, and, ultimately, lead to hospital readmission. Aim 1 Determine the associations between SDoH and
16 the 30- and 90-day post-hospitalization outcomes among racially diverse patients with advanced (Stage C/D)
17 HF. Aim 2 Identify HF patient perceptions and associated contextual factors of SDoH that influence the
18 achievement of goal-concordant care outcomes among patients with advanced HF living in the community.
19 Methods: We will conduct a prospective, concurrent mixed-methods triangulation study with quantitative and
20 qualitative (quant+QUAL) methodologies to contextualize the experiences of patients with advanced HF post-
21 hospitalization. Inclusion criteria: >18 years-old, hospitalized at the study site, diagnosed with advanced
22 (ACCF/AHA Stage C or D) HF, Meta-Analysis Global Group in Chronic Heart Failure Integer risk score >18
23 (range 0–52). Exclusion criteria: current enrollment in hospice, having a plan for cardiac procedures/surgical
24 therapy within six months, or having a documented non-cardiac terminal illness. Analysis: For binary readmission
25 outcomes, we will use multivariable logistic analysis to evaluate whether SDoH variables associated with
26 readmissions at 30 and/or 90 days. Qualitative analysis will be conducted on patient interviews with vanManen’s
27 phenomenological approach. Findings: Findings from this study will further health equity science by providing
28 the empirical and contextual evidence needed to fill gaps in our understanding about putative SDoH-related
29 individual, systematic, and community-based drivers of post-hospitalization patient-centered HF outcomes in
30 diverse populations with advanced HF.

Public health relevance
PROJECT NARRATIVE Many individuals with advanced heart failure experience poor outcomes including frequent admissions to the hospital. These outcomes are worse in racial and ethnic minority groups resulting in health inequities. Health inequities are often associated with social determinants of health (SDoH), which are the economic and social conditions that influence health. This project will investigate the SDoH of individuals with advanced heart failure and determine how their SDoH may influence future hospitalizations and if patients are receiving care in alignment with their values and goals. These findings will inform current care practices and provide a foundation for future studies to support patients with advanced heart failure more holistically.